Addressing the Needs of Key Subgroups of Caregivers of Persons with Dementia After Loss Using Self-Determination Theory: A Mixed Methods Approach

Project Summary / Abstract
Within 10 years, most persons living with Alzheimer’s disease and related dementias (AD/ADRD; PLWD) will
die, creating 13+ million new bereaved AD/ADRD caregivers. 25% of bereaved AD/ADRD caregivers have
clinically ‘complicated grief’, which impairs nearly all aspects of their lives. Among bereaved AD/ADRD
caregivers who are not clinically impaired, millions still suffer from higher depressive symptoms and loneliness
as well as reduced well-being, physical function, self-care, and personal growth. Researchers may be tempted
to treat bereaved AD/ADRD caregivers as a homogenous group, but bereavement differs between key kin
subgroups of spouses and adult children. Unfortunately, how bereavement differs for extended family is difficult
to discern. The long-term goal of this research is to develop interventions to meet the needs of bereaved
AD/ADRD caregivers. The objective of this proposal is to test a comprehensive model of bereaved AD/ADRD
caregiver needs and identify need satisfying experiences within key kin subgroups that are amenable to future
intervention. The central hypothesis is that bereaved AD/ADRD caregivers have a common set of needs that
influence clinical and subclinical outcomes, but that subgroups meet those needs in different ways, based on
evidence from self-determination theory and 10 months observing bereaved AD/ADRD caregivers. Autonomy,
competence, and relatedness are hypothesized to form a common set of needs essential to clinical and
subclinical outcomes for bereaved AD/ADRD caregivers (Aim 2; tested in a survey of 400 bereaved AD/ADRD
caregivers). Key subgroups are hypothesized to meet these needs differently (Aim 3; tested in semi-structured
interviews with 36-45 bereaved AD/ADRD caregivers). Through a tailored training plan and world-renowned-
expert mentorship in one of the nation’s foremost schools of public health, the candidate will gain expertise in
bereavement, stakeholder engagement, qualitative methods, and mixed methods to facilitate completion of the
long-term goal of this research. Complementing the research team, a Community Advisory Board (CAB) of
bereaved AD/ADRD caregivers and stakeholders will advise the present project and the PI’s broader research
program aimed at helping bereaved AD/ADRD caregivers. CAB members represent different races, ethnicities,
sexes, genders, ages, clinical specialties, types of dementia, time since bereavement, community
organizations, and geographic locations. After this award, the CAB will help guide development of interventions
based on the findings of Aims 2 and 3. The proposed research is innovative in its focus on key subgroups,
application of self-determination theory, and diverse CAB focused on bereaved AD/ADRD caregivers. The
work will address the NIA’s goal to increase understanding of bereaved AD/ADRD caregivers’ needs, informing
future interventions that reduce the clinical and subclinical consequences of bereavement. Together the
integrated research strategy and training plan will also facilitate a successful transition to independence for a
researcher committed to helping PLWD and their caregivers thrive throughout the dementia caregiving journey.

Public health relevance
Project Narrative Bereaved AD/ADRD caregivers are at elevated risk for clinically pathological and subclinically problematic consequences and their numbers are increasing quickly. This proposal aims uses a model based on self- determination theory to understand the needs of bereaved AD/ADRD caregivers while accounting for the differences in the ways those needs are satisfied among key subgroups. The wider goal of this research is to use the understanding of bereaved AD/ADRD caregivers’ needs to create interventions to satisfy those needs, reducing the clinical and subclinical consequences of bereavement.